Advancing Conformance with the Voluntary National Retail Food Regulatory Program Standards

Project Summary/Abstract For Colorado’s Retail Food Program Proposal to Expand Standardized Statewide Data System Capture of Inventory and Inspection Results in Support of the Voluntary National Retail Food Regulatory Program Standards The intent of this cooperative agreement award is to increase the number of local public health agencies in Colorado using a statewide Retail Food Program data system. In an effort to expand uniformity among the local regulatory programs responsible for food protection in Colorado, the goal of this cooperative agreement is to assist the 18 local agencies that currently use disparate data systems in a migration to the statewide data platform. This project will improve conformance with multiple Retail Food Regulatory Program Standards, including Standards 1, 3, 4, 6 and 8. The pace and order of local agencies migrating into the Colorado Retail Food data system will be determined by the pace at which those agencies can prepare data into formats suitable for migration, the effective date of pending regulation revisions, the stability of current local data systems, and availability of funds. This project anticipates at least two and as many as five counties migrating into the Colorado data system each year during the three-year project period.

Public health relevance
Project Narrative For Colorado’s Retail Food Program Proposal to Expand Standardized Statewide Data System Capture of Inventory and Inspection Results in Support of the Voluntary National Retail Food Regulatory Program Standards It is the intent of the Colorado Department of Public Health and Environment’s Division of Environmental Health and Sustainability (CDPHE-DEHS) to use this opportunity to increase the number of local public health agencies using a statewide Retail Food Program data system. Currently 63 counties in Colorado are covered by the Retail Food Program. Of these, 45 counties utilize CDPHE’s uniform data system to manage inventories, calculate risk-based inspection frequencies, capture inspection results, and manage enforcement follow-up. In an effort to expand uniformity among the local regulatory programs responsible for food protection in Colorado, our goal is to assist the 18 local agencies that currently use disparate data systems in a migration to the statewide data platform. This project will improve conformance with multiple Retail Food Regulatory Program Standards. Colorado is in the process of a rulemaking to adopt the 2013 FDA Model Food Code as the Colorado regulation. The CDPHE Retail Food Program data system currently supports the FDA Food Code, while some local systems do not. This will improve conformance with Standards 1 and 4. The CDPHE data system incorporates a three-tier risk categorization for food establishments and automatically calculates inspection frequencies based on risk. The data system also automatically schedules and tracks inspection follow-up and enforcement activities. This will improve conformance with Standards 3 and 6. CDPHE supports the costs of implementing and maintaining the Retail Food data system at little or no costs to local agencies, increasing the availability of local revenues to support other program needs. This will improve conformance with Standard 8. The pace and order of local agencies migrating into the CDPHE Retail Food Program data system will be determined by the pace at which those agencies can prepare data into formats suitable for migration, the effective date of pending regulation revisions, and the stability of current local data systems. This project anticipates at least two and as many as five counties migrating into the CDPHE data system each year during the three-year project period.